Early childhood communication outcome measures for DS

Project Summary/Abstract
A diverse array of pharmaceutical treatments has been reported to successfully rescue, or partially rescue,
learning and memory deficits in the Down syndrome mouse model Ts65Dn. These advances have led to calls
for a more robust national translational research agenda for DS. However, the evaluation of the efficacy of
targeted treatments for DS has been hampered by a lack of outcome measures that have been validated for
DS. The need for validated outcome measures for DS is particularly acute for the earliest years of life because,
presumably, interventions that begin early have the greatest potential to create a cascade of positive events
that can have cumulative, pervasive, long-lasing benefits. Unfortunately, such measures are virtually
nonexistent prior to the school-age years. In the present project, we propose to evaluate the feasibility and
psychometric properties of a variety of prelinguistic and spoken language metrics collected in naturalistic
contexts, which have been used in research and clinical practice to track developmental improvements in a
number of populations of children, for use in treatment studies focused on young with DS. The focus on
language and communication as endpoints for treatment studies of DS is particularly attractive given that
difficulties in these domains are among the most salient features of the DS phenotype. In this project, we
propose to (1) evaluate the psychometric properties of five metrics of prelinguistic communication skills, (2)
evaluate the psychometric properties of four metrics of early spoken language skills, and (3) characterize the
developmental trajectories of these various metrics of prelinguistic and spoken language in young children with
DS through cross-sectional approaches. These aims will be addressed by collecting two naturalistic
communication samples from children with DS aged 2.50-7.99 years: Early Social Communication Scales
(ESCS) and a semi-structured play session with an examiner. Measures derived from the samples will include
those indexing prelinguistic communication (e.g., ESCS Initiating Joint Attention, Initiating Behavioral
Requests, and Initiating Social Interaction scores; Communication Complexity Scale score; Expressive
Communication Index-Weighted Communication score) and spoken language (e.g., talkativeness, lexical
diversity, syntactic complexity, intelligibility). Test-retest reliability will be assessed over 2 weeks (+/-3 days).
Standardized measures will be used as indicators of construct validity. A 1-year longitudinal follow-up will yield
an estimate of relative sensitivity to change of the various measures. Feasibility of multiple-site implementation
will be evaluated by comparing samples across sites on key psychometric indicators. The developmental
trajectories of these metrics will be explored by describing performance as a function of subject characteristics
(e.g., chronological age, nonverbal cognition, and verbal cognition).

Public health relevance
PROJECT NARRATIVE Recent basic science discoveries using mouse models and advancements in the development of new pharmacological and behavioral interventions targeting core symptoms of Down syndrome (DS) have led to calls for a more robust translational research agenda for DS. However, the evaluation of the efficacy of targeted treatments for DS has been hampered by a lack of outcome measures that have been validated for DS, particularly during the earliest years of life. In this project, we propose to validate a variety of early communication and spoken language measures for use in treatment studies focused on young children with DS.